Neuroimaging and Plasma Biomarkers Core

The goal of the Neuroimaging and Plasma Biomarkers Core (Biomarkers Core) of the Diabetes Prevention
Program Outcomes Study (DPPOS) Alzheimer’s disease (AD) and AD related dementias (ADRD) project is to
conduct all training, certification, quality assurance (QA) and quality control (QC) activities related to brain
magnetic resonance imaging (MRI), brain amyloid positron emission tomography (PET) imaging, and plasma
biomarkers of amyloid, tau, neurodegeneration, and neuroinflammation. In addition, the Biomarkers Core will
support the Biostatistics and Data Infrastructure Core (Data Core) and the Cognitive Assessment and
Adjudication Core (Cognition Core) to conduct analyses of neuroimaging and plasma biomarkers as independent
outcomes and in combination with cognitive outcomes, following the 2018 National Institute on Aging
(NIA)/Alzheimer’s Association (AA) research framework. The Biomarkers Core will harmonize methods for the
study of the vascular contribution to cognitive impairment and dementia (VCID), with the MarkVCID consortium.
Determination of biomarkers underlying AD/ADRD is critical to understanding disease mechanisms and potential
therapeutic targets underlying cognitive impairment in persons with pre-diabetes (PreD) and type 2 diabetes
(T2D), who represent over half of the US population aged 60 years and older at risk for cognitive impairment.
We herein propose to perform multimodality MRI, including structural imaging, diffusion tensor imaging (DTI),
cerebral blood flow, and functional MRI and amyloid PET in 650 participants representative of the DPPOS cohort
in one wave that will span the two proposed waves of cognitive assessments. We also propose to conduct
ascertainment of plasma biomarkers of amyloid (Aß42, Aß40), tau (ptau-181), neurodegeneration (neurofilament
light [NfL]), neuroinflammation (glial fibrillary acidic protein [GFAP]), and peripheral neuropathy (peripherin) in all
participants concurrent with the first wave of cognitive assessments, and two previous waves, 5 years apart,
from stored samples. The Biomarkers Core is led by Ilya Nasrallah at the University of Pennsylvania, who will
lead all brain imaging core activities, and Henrik Zetterberg at the University of Gothenburg, who will lead all
plasma biomarker core activities. The Biomarkers Core will achieve its goals through the following specific aims:
(1). To develop, maintain, update, and implement protocols and QA/QC procedures related to brain MRI and
amyloid PET; (2) Develop an imaging pipeline for evaluation of AD and VCID biomarkers; (3) Conduct assays of
Aß42, Aß40, ptau-181, NfL, GFAP, and peripherin, using Single Molecular Array (Simoaä) at the central plasma
biomarkers laboratory located at the University of Gothenburg; (4) Conduct exploratory analyses relating brain
imaging and plasma biomarkers data in collaboration with the Data and Clinical Cores; (5) In collaboration with
the Data, Cognition, and Clinical Operations and Procedures Core (Clinical Core), further adjudicate MCI and
dementia using AD/ADRD biomarkers and assist with analyses involving neuroimaging and plasma biomarker
data; (6) Assist the Clinical Core in the return of results of amyloid positivity to participants who so request.